Exposure Biology Informatics Facility Core

EXPOSURE BIOLOGY INFORMATICS CORE (EBIC): ABSTRACT
The Exposure Biology Informatics Core (EBIC) is dedicated to providing informatics support to CEET
investigators in the areas of chemoinformatics resource management and analysis, bioinformatics application
development, multi-omics data management and integration, next-generation sequencing (NGS) data analysis,
biomedical informatics to extract data from the Electronic Health Record (EHR), computer programming,
artificial intelligence and machine learning, and data visualization. For this purpose, we have assembled a
diverse team of experts with complementary skills in computer science, data science, and genomics to build a
powerful informatics infrastructure that is prepared for biomedical and environmental big-data. The vision for
EBIC is to provide seamless support for routine use of innovative computational methods that embrace the
complexity of exposure biology and environmental health and enable the conversion of big-data into knowledge
to advance Precision Public Health (PPH). A central goal of the EBIC is to work closely with CEET investigators
in both a collaborative and support role to understand adverse outcome pathways (AOP) or constructs that go
from the exposure to molecular initiating events to downstream key events to organism and population health
outcomes. The primary objectives of the EBIC are organized around eight specific aims. In Aim 1: we will provide
state-of-art informatics services to research groups that otherwise would not have access to these computational
approaches. In Aim 2: We will support the CEET thematic areas in Air Pollution & Lung Health, Environmental
Exposures & Cancer, Windows-of-Susceptibility, and Environmental Neuroscience with informatics services. In
Aim 3: We will optimize EBIC services through prioritization. In Aim 4: We will support the CEET pilot projects
with informatics services. In Aim 5: We will provide access to state-of-the-art computational equipment and
software. In Aim 6: We will ensure that EBIC supports the activities of the Integrative Health Sciences Facility
Core and the Translational Biomarker Core with informatics support for human subject/population research. In
Aim 7: We will provide educational opportunities and training in informatics which is an optional experience for
Early Stage Investigators. In Aim 8: We will disseminate informatics, data software and new tools to the larger
environmental health sciences community .